Multimodal MEAs for Parallel Electrical Recording and Sub-second Neuromodulator Sensing

Abstract
It has been highly challenging to scale up non-genetic, sub-second neuromodulator sensing or integrate it with
electrical recording. Recently, we discovered that mild annealing dramatically improved the electrochemical
stability of electroplated carbon coating and transformed conventional microelectrodes into sensors similar to
carbon fiber electrodes with excellent neuromodulator-sensing performance based on fast-scan cyclic
voltammetry (FSCV). Compared to previous carbonization strategies such as pyrolysis of polymer and laser-
induced graphitization, low-temperature, FSCV-stable carbon coating is directly applicable to microelectrode
arrays (MEAs), enabling unprecedented spatial scaling of FSCV and unparalleled integration with
electrophysiological (ephys) recording, while leveraging decades of MEA research and applications. As a
demonstration, we have created a monolithic MEA probe with integrated ephys and FSCV capabilities and
validated it in vivo in multiple rodent models. Early studies using this probe in awake rats further revealed an
unprecedented correlation between striatal gamma oscillation and dopamine release. In three parallel aims, we
intend to optimize, benchmark, and thoroughly validate the platform ephys-FSCV MEA probe for high-density
neuromodulator sensing and parallel electrical recording in behaving animals. Our multidisciplinary team
consists of a materials scientist and neural engineer (Fang) and a systems neuroscientist (van der Meer), who
have jointly produced strong preliminary results with successful in vivo validation and neuroscience studies.
In addition to establishing the significant and novel multimodal MEA paradigm, which we envision will enable
numerous studies in basic and translational neuroscience, we anticipate that the concept of FSCV-stable
carbon-coating and the bioengineering of its up-scaling and ephys-integration are generalizable to many other
probes, such as DBS and sEEG electrodes and extensible to further technology evolutions and commercial
manufacturing.

Public health relevance
Project Narrative This study aims to transform microelectrode arrays into a multimodal platform technology capable of parallel neuromodulator sensing. This powerful multimodal-MEA paradigm is expected to directly enable new hypothesis-driven neuroscience studies by overcoming major barriers to scaling up in vivo neurochemical measurements and integrating them with electrical recordings in highly challenging spatial and temporal domains. The knowledge from this project will also be broadly applicable to a large and increasing group of neural probe implants for research and clinical use.